The Pacific Northwest Prostate Cancer SPORE

PROJECT SUMMARY/ABSTRACT
The Pacific Northwest (PNW) Prostate Cancer SPORE continuation grant represents a coordinated effort of four
institutions with established programs and strengths in translational prostate cancer research including basic,
clinical, and population sciences as well as career development: 1) the Fred Hutchinson Cancer Center (FHCC);
2) the University of Washington (UW) and its affiliated institutions; 3) the University of British Columbia and the
Prostate Centre of Vancouver General Hospital (UBC); and 4) Oregon Health and Science University (OHSU).
These Seattle-, British Columbia- and Portland-based institutions have large multidisciplinary teams of
investigators and laboratories dedicated to prostate cancer research and a history of working closely together
within this larger milieu. The respective teams of clinicians and researchers at these institutions bring
considerable scientific depth, breadth, creativity, and vision required for confronting the most challenging
problems blocking progress in our ultimate goal of reducing the morbidity and mortality associated with prostate
cancer. This SPORE proposal enlarges the blueprint for a well-built, distinctive and coordinated translational
prostate cancer research effort spanning the entire PNW.
All participating institutions have made substantial commitments toward supporting the SPORE and its
innovative, translational projects: 1) Molecular predictors of prostate cancer progression and mortality; 2)
Understanding and targeting prostate cancer lineage plasticity; 3) Modulating androgen receptor signaling to
enhance the efficacy of CAR T cell therapy for advanced prostate cancer; and 4) Clinical development of
therapeutic strategies targeting DNA repair. We also propose three Cores to support these projects: 1)
Leadership and administration; 2) Biospecimen and Pathology; and 3) Biostatistics and Bioinformatics. In
addition, we propose a Developmental Research Program and a Career Enhancement Program that will
substantially strengthen the translational goals of our prostate cancer research program and expand
opportunities for engaging young as well as established investigators in our multidisciplinary environment.

Public health relevance
PROJECT NARRATIVE Prostate cancer (PC) is a major cause of cancer incidence and mortality in US men. This year alone 230,000 men will be diagnosed and 30,000 will die of the disease; and worldwide, the annual number of men dying from PC is increasing. This highlights the urgent need for translational PC research to uncover the underlying genetic and genomic factors and pathways – including environmental and social contributions - that drive PC toward its lethal phenotype.